Administrative Core

Core C: Administrative Core The Administrative Core will provide support for the Program Director in coordinating the overall Program Project Grant. The specific responsibilities of the Administrative Core include: 1) overseeing the distribution of scientific core resources to the four individual research projects;2) managing the weekly PPG Seminar Series including scheduling, arranging for travel and itineraries for visiting outside speakers;3) developing and maintaining a website for the PPG to permit outside investigators access to services and reagents developed through the PPG;4) preparing annual budget reports as required by the University of Michigan and the National Institutes of Health;5) organizing the Program review by the External Adviosry Board and the Internal Adviosry Board;6) overall post-award management including fiscal oversight and assurance of compliance with NIH guidelines.